Biophysical and functional characterization of immune-related regulatory elements and noncoding variants

Project Summary
Susceptibility to diverse immune diseases has been associated with genetic differences that affect
gene expression. Understanding the mechanisms by which these genetic differences lead to disease
has been a central goal of genomic efforts aimed at describing disease mechanisms and identifying
targets for therapeutic treatments. While large-scale studies have identified thousands of genetic
differences associated with immune diseases, in most cases, it is not known which variants are
causal and which are non-causal passenger variants. This is a considerable problem for the many
variants that exists in non-coding regions of the genome for which function is difficult to predict. Thus,
there is a critical need for the high-throughput experimental approaches to characterize the function
and mechanism of the many non-coding variants associated with immune diseases. To tackle this
challenge, we will use two complementary high-throughput approaches to study the impact of genetic
variants on immune gene expression. We will use MPRAs (Massively Parallel Reporter Assays) to
study the impact of genetic variants on gene expression. We will use our recently developed
CASCADE (Comprehensive Assessment of Complex Assembly at DNA Elements) approach, in
conjunction with mass spectrometry-based studies, to profile the impact of genetic variants on TF-
cofactor complex binding. We will use these approaches to characterize (1) the impact of genetic
variants on ~30 immune gene regulatory elements, and (2) ~5000 genetic variants found to be
associated with immune disease or altered gene expression. Combining these approaches will
address both function and biophysical mechanism of genetic variants in a cell- and stimulus-specific
manner. Furthermore, as many regulatory cofactors can be inhibited with drugs, characterizing TF-
cofactor complexes bound at genetic variants provides an opportunity to identify therapeutics to
counteract their effects. Altogether, by integrating complementary, high-throughput approaches that
directly account for effects of cell type and cell stimulation, the proposed studies will identify the
mechanisms by which non-coding variants affect gene expression and immune diseases.
Furthermore, these studies will lay a foundation for translating large-scale genetic studies into
therapeutic approaches to treat for immune diseases.

Public health relevance
Project Narrative Large-scale studies have identified thousands of genetic variants associated with immune diseases, most of them located in regions of the genome that alter gene expression. However, in most cases, it is not known which of these variants drive disease phenotypes, nor their mechanism of action. In this proposal, we will integrate complementary experimental approaches to identify potential causal genetic variants and determine the molecular mechanisms by which they affect gene expression and lead to immune disease. !